Assessing the Contribution of Cortical Hyperactivity to ALS Phenotypes in a Human-Derived Motor System

PROJECT SUMMARY/ABSTRACT
Amyotrophic Lateral Sclerosis (ALS) is a lethal neurodegenerative disease characterized by motor neuron
degeneration. While the presentation of ALS involves progressive loss of motor function, the mechanistic
cause(s) of ALS are unknown. Patients diagnosed with ALS may have one of several identified genetic mutations
which predispose them to ALS, or they may present no known genetic variation; they may have a familial history
of disease, or they may be the first known case in their family. This heterogeneity has complicated our ability to
model ALS, obscuring the identification of causative mechanisms in this disease. Current model systems of ALS
are limited to exploring the resulting pathologies in animals or cell lines with a single mutation, which ultimately
is not representative of the ALS patient population. Furthermore, findings in these models have failed to translate
in the vast majority of clinical trials. Remarkably, cortical hyperexcitability is an early biomarker of ALS regardless
of genetic background, and it precedes motor symptoms and diagnosis. Despite the well-documented evidence
of this early, common phenotype, no study has demonstrated the consequences of this phenomena in human
tissue. Cortical projection neurons are in close contact with interneurons, motor neurons, and astrocytes at the
cortico-spinal synapse, and we hypothesize that cortical hyperexcitability can induce ALS phenotypes in these
populations. Completion of this proposal will determine the effect of cortical hyperexcitability on these
three cell-types key to ALS pathology. This proposal will leverage the growing field of human organoid
systems to address the lack of access to functional human tissue. Cortico-motor assembloids are formed by
assembling human stem cell-derived cortical, spinal, and muscle spheroids. Neurons from the cortical spheroid
project to the spinal spheroid. Motor neurons from the spinal spheroid functionally project to the muscle spheroid
and induce its contraction. By chronically stimulating the cortical spheroid using optogenetic paradigms informed
by findings in the ALS literature, I will recapitulate an early phenotype of ALS within a model derived from healthy
control cells, detangling the potential contribution of genetic background. In Aim 1, I will interrogate changes in
interneuron and motor neuron populations in the spinal spheroid after stimulation. Drawing from findings in ALS
patients and models, we will measure changes in the proportion of inhibitory synapses in the spinal spheroid, as
well as changes in muscle innervation and contraction. In Aim 2, I will isolate astrocytes from the spinal spheroid
after stimulation and evaluate their ability to transport glutamate, an essential astrocyte function which is
compromised in ALS patient-derived tissue. Completion of these aims will begin to elucidate the relationship
between disparate ALS pathologies, paving the way towards the identification of disease-modifying targets which
are sensitive to the early cortical hyperexcitability phenotype.

Public health relevance
PROJECT NARRATIVE Cortical hyperexcitability is an early phenotype of the devastating neurodegenerative disease Amyotrophic Lateral Sclerosis (ALS) which presents across patients of heterogenous genetic backgrounds. The proposed research will determine the effects of cortical hyperexcitability on cell types in the spinal cord key to this disease’s pathology: motor neurons, interneurons, and astrocytes. These experiments are expected to reveal the consequences of early cellular dysfunction in ALS in human cells, ultimately leading the way towards identifying therapeutic targets and thereby furthering the missions of the NIH and NINDS to use fundamental knowledge about the nervous system to reduce the burden of neurological disease for all people.